The role of the nucleus accumbens in exercise-induced stress resistance

PROJECT SUMMARY
The prevalence of stress-related disorders has surged globally. Although females are twice as likely as males
to develop a stress-related disorder, they remain markedly underrepresented in preclinical research
investigating stress resistance factors and their associated mechanistic pathways. Exercise is an important
resistance factor with a broad range of stress-buffering effects that are not only highly conserved across
species but develop more rapidly in females than males. Preclinical models demonstrate that voluntary wheel
running (VWR) prevents the typical depressive- and anxiety-like outcomes of inescapable stress (IS) in rats,
and importantly, females attain stress resistance more rapidly (3 weeks of VWR) than males (6 weeks of
VWR). Exercise affords behavioral stress resistance at these timepoints by constraining the serotonergic (5HT)
response in the dorsal raphe nucleus (DRN), however the mechanisms underlying this constraint are unknown.
My preliminary data reveal a robust inhibitory pathway from the nucleus accumbens (NAc) to the DRN that is
positioned to inhibit the activity of DRN 5HT neurons during stress and is primed by prior exercise. This
proposal explores whether the NAc is critical for the protective stress effects of exercise, at least in part,
through GABAergic projections to DRN 5HT neurons. My preliminary data reveal that 6 weeks of VWR in
males potentiates IS-induced activity of DRN-projecting NAc neurons. Notably, the NAc displays differences in
neural morphology and enhanced stimulus-evoked dopamine females, which could account for the accelerated
acquisition of exercise-induced stress resistance in female rats. Aim 1 will examine whether prior VWR
engages the NAc-DRN pathway during IS in both sexes, and whether this process occurs earlier in females
compared to males, using viral tracing and fluorescent in situ hybridization. Given the temporal differences of
stress resistance between VWR males and females, I hypothesize that prior exercise will increase IS-induced
cfos in DRN-projecting GABAergic NAc neurons in males after 6 weeks and in females (but not males) after 3
weeks. Aim 2A will examine whether chemogenetic inhibition of the NAc-DRN pathway during IS will prevent
exercise-induced resistance to the behavioral outcomes of IS, such as social avoidance and exaggerated fear.
Aim 2B will utilize in vivo fiber photometry to examine whether chemogenetic inhibition of the NAc-DRN
pathway during IS restores the DRN 5HT response to IS, despite sufficient exercise experience. Preliminary
data suggest that males recruit multiple mechanisms for the stress-protective effects of exercise, such as IS-
induced activity from prefrontal cortical neurons. In contrast, my preliminary data suggest that females rely on
the NAc-DRN pathway as a single, distinct stress resistance mechanism. Therefore, I hypothesize that NAc-
DRN pathway inhibition during IS will eliminate the protective effects of VWR on IS-induced 2A) behavioral
outcomes and 2B) DRN 5HT activity in female, but not male rats. Collectively, this proposal aims to investigate
the underlying mechanisms of exercise-induced stress resistance and the sex differences therein.

Public health relevance
PROJECT NARRATIVE Traumatic life events result in negative health outcomes for both men and women, however, women are twice as likely as men to develop a stress-related disorder following a traumatic event. Exercise is a powerful resistance factor with a broad range of stress-buffering effects that develop more rapidly in females than males, although the underlying mechanisms are unknown. The current proposal will determine the role of a nucleus accumbens-to-dorsal raphe nucleus pathway in mediating exercise-induced stress resistance, and particularly the rapid acquisition of exercise-induced stress resistance in females.